Admin Core

ABSTRACT – ADMINISTRATIVE CORE
The ROAR administrative core will be responsible for the overall management, coordination, and oversight of all
aspects of the ROAR consortium under the direction of the MPIs (Dr. V. Reid Sutton and Dr. Lindsay
Burrage). The MPIs will work closely with the ROAR administrative coordinator and the executive leadership
committee to lead the ROAR consortium with input from an external advisory committee and two patient
advocacy groups (PAGs). The administrative core will also provide statistical and bioinformatics support for all
ROAR investigators and ROAR projects through a biostatistics and bioinformatics core. The administrative core
will lead the consortium with the following specific aims: 1) Establish subcontracts and coordinate funds
allocation and transfer within the ROAR consortium, 2) Coordinate communications and organize meetings for
the ROAR consortium. 3) Manage and oversee regulatory documentation, clinical documentation, data
management, data sharing policies, NIH progress reports, and project milestones among ROAR consortium
sites, the NIH, the DMCC, and the central IRB and data safety monitoring board, 4) Establish an external advisory
committee and organize ROAR consortium meetings with the external advisory committee, 5) Engage and
disseminate information about the ROAR consortium in collaboration with ROAR consortium sites, the RDCRN
DMCC, and the ROAR patient advocacy group partners, and 6) Provide statistical and bioinformatic support
services for all ROAR consortium sites.